An analytical technique to evaluate early auditory evoked potential morphology

PROJECT SUMMARY / ABSTRACT
Diagnostic tests for hearing loss miss many underlying sensory and neural pathologies that contribute to hearing
problems. Treatments such as hearing aids and cochlear implants are prescribed without knowledge of the
underlying site-of-lesion or remaining function, resulting in large variability in benefit and satisfaction.
Furthermore, undetected and unaccounted for pathologies may be a cause of the mixed success in current
clinical trials of pharmaceutical treatments for hearing loss. Early-latency auditory evoked potentials (AEPs) are
an objective measure of auditory physiology that could identify and differentiate sensory and neural pathologies.
Despite the clinical availability of early-AEPs, there are barriers to their widespread use that we argue largely
result from reliance on visual inspection of features in the evoked response waveform to identify pathology.
Reliable analysis using visual inspection requires significant training and more time than is customary for a typical
hearing evaluation appointment. Reliable interpretation requires experience that is too burdensome for a non-
specialist. A recently developed technique overcomes these barriers by automatically analyzing the response
waveform and extracting more features than can be seen by the human eye. Though the preliminary version of
the technique's analysis is automatic, it requires some manual adjustment beforehand to work on each new
dataset. Furthermore, there is minimal existing research on the benefit of the additional extracted features
analyzed by the technique in their ability to identify certain auditory pathologies. Therefore, the proposed study
has two aims. The first aim automizes the adjustment process of the technique such that it works immediately
on early-AEPs from different species, stimuli, and recording parameters. The second aim tests whether the
features analyzed by the technique can better identify several sensory and neural pathologies in animals than
the traditional method of visual inspection. To achieve these aims, existing AEP responses from human and
animal research labs will be collected. The technique will be trained to work automatically on healthy human and
animal waveforms, similar to training artificial intelligence, with an expected outcome being a user-friendly
technique that requires minimal input (e.g., species and stimulus rate) to automatically analyze responses. For
the second aim, several animal models of different sensorineural diseases will be used to compare the technique
to visual inspection and other automated approaches in their ability to identify diseased ears from healthy
controls. The proposed study is the next step on the path to creating a no-cost user-friendly tool for automated
analysis and assistance in interpreting features to identify disease. This effort is needed to work toward a
subsequent R01 translating animal morphological biomarkers to human early-AEPs. The long-term goal of this
line of research is to identify pathologies underlying sensorineural hearing loss so that new treatments can be
developed that target specific pathologic mechanisms in the ear.

Public health relevance
PROJECT NARRATIVE Electrophysiological measures of auditory health and function have the potential to provide critical information currently missing from clinical hearing tests; however, they have historically relied on a highly trained human eye to analyze and interpret features of the electrical responses, limiting their clinical use and what features are researched. The proposed research develops a free, automated tool for analysis and interpretation of electrophysiological measures that would allow clinicians and researchers to use features that cannot be measured by the human eye to identify sensorineural pathologies causing hearing loss. The research goals align with Themes 1 and 5 of the National Institute on Deafness and Other Communication Disorders (NIDCD) Strategic Plan by identifying new biomarkers of sensorineural function and using machine learning to train and automate the analytical tool, resulting in improved clinical diagnosis and prognosis, and development of targeted pharmaceutical research.